Dissecting the role of vasopressin in regulating the critical period for social reward learning

PROJECT SUMMARY:
The overall objective of the studies proposed in this revised R01 application is to elucidate the molecular
mechanisms underlying regulation of social brain development, a first step in a larger project aimed at
identifying circuit based approaches which improve therapeutics for neurodevelopmental disorders
characterized by social impairments, as well as diseases which may be the consequence of social injury during
brain development. Based on extensive preliminary findings, our overall hypothesis is that developmental
upregulation of arginine vasopressin (AVP) signaling constrains social reward learning to a critical period, and
that these functions are enabled by presynaptic AVP receptors in the ventral pallidum (vPD). The goal of this
R01 application is to explore this understudied area and to develop tools to test our hypothesis directly in vivo
and ex vivo. Three specific aims have been proposed to achieve our goal. Specifically: Specific Aim 1: To
map and characterize the AVP neuronal projection from the hypothalamus to the vPD. Here we will test
the hypothesis that the vPD receives a parvocellular AVP neuronal projection from the hypothalamus. Specific
Aim 2: To determine whether AVP evokes synaptic plasticity in the vPD across development. Here we
will test the hypothesis that the magnitude of AVP induced synaptic plasticity in the vPD is increased across
development. Specific Aim 3: To determine whether AVP1a receptors in the vPD are required for
constraining the social reward learning critical period. Here we will test the hypothesis that AVP1a
receptors in the vPD are required for the closure of the social reward learning critical period. We predict these
studies will demonstrate the reciprocal regulation of OT and AVP as a mechanism underlying the
establishment of a critical period for social reward learning. In addition, these studies are designed to identify a
novel manipulation (blockade of the AVP1aR) that can reinstate social reward learning in adulthood, which will
have important implications for future clinical trials of mechanism-based therapies for the treatment of autism,
schizophrenia, addiction and post-traumatic stress disorder. Moreover, because these studies characterize a
quantifiable measure of social reward learning (social conditioned place preference) that can be used in both
humans and mice, they dramatically improve the translational validity of these studies for future development
of therapeutic interventions.

Public health relevance
PROJECT NARRATIVE Social interactions are critical to the normal development of the brain. A critical period is a developmental epoch during which the nervous system is expressly sensitive to specific stimuli that are required for experience dependent learning, circuit organization, and synaptic plasticity. Critical periods have been described for both sensory (e.g. vision, touch) and social (e.g. language, imprinting) functions. While mechanistic insights into the establishment and reinstatement of sensory critical periods have transformed therapeutic practice (e.g. for treating deafness and blindness), to date, the molecular, synaptic, and circuit mechanisms underlying social critical periods are largely unknown. Our proposed studies will have significant implications for understanding the pathogenesis of neurodevelopmental disorders characterized by social impairments, such as autism and schizophrenia, as well as diseases like addiction and PTSD that respond to social influence or are aggravated by social injury. At the same time, these insights will provide the basis for new therapeutic strategies, improved mechanistic understanding of therapeutic interventions currently in clinical trials, and objective measures of social reward learning across maturation that are tractable for future translational studies.